Real-time and subjective predictors of vape pod use among young adults with mental health concerns

PROJECT SUMMARY/ABSTRACT
Electronic Nicotine Delivery Systems (“ENDS”) use among young people has increased dramatically over
the past two years, largely due to the increase in popularity of vape pods, a novel type of ENDS product that
delivers nicotine and flavorings through “nicotine salts.” This rapid increase in use is alarming given the high
potential for nicotine dependence; vape pods contain the highest nicotine concentrations of ENDS on the
market. While the research on vape pod use is still nascent, one population that may be uniquely susceptible
to use includes YAs with mental health concerns. YAs with mental health concerns report higher use of
tobacco products, including ENDS, than their peers. Recent research has found that symptoms of depression
and anxiety are positively associated with ENDS use behaviors among YAs. The associations between mental
health concerns and ENDS use among YAs is concerning as individuals with mental health concerns suffer
disproportionately from tobacco-related health effects and report greater difficulty in quitting as compared to
the general population. Nicotine dependence is particularly problematic among this population as nicotine
causes fluctuations in mood, such as depressive symptoms and stress, which, in turn, may lead to more
frequent use among these individuals. To date, there is limited research investigating factors associated with
ENDS use generally, and vape pod use specifically, among YAs with mental health concerns. Such information
is needed to inform the development of tailored cessation intervention efforts for this vulnerable population. In
order to fill the gap in understanding novel tobacco product use (i.e. vape pod use) among YAs with mental
health concerns, this study will utilize state-of-the-science ecological momentary assessment (EMA) and
qualitative interviews to investigate real-time antecedents of vape pod use among YAs with symptoms of
depression and/or anxiety. Thus, this study has the following aims: 1) to assess real-time predictors of vape
pod use, as well as patterns of use, in a prospective study of YAs (n=50) with symptoms of depression and/or
anxiety by using EMA, and 2) to explore perceptions of vape pod use and recommendations for future vape
pod cessation interventions through the use of qualitative interviews (n=50). The EMA portion of the study will
investigate antecedents of use, including social setting, concurrent substance use (other tobacco products,
alcohol, and marijuana), mood, craving, among others. As EMA cannot capture all relevant constructs, we will
supplement our EMA analyses with qualitative interviews. Qualitative interviews will provide important insights
and context regarding our EMA findings, as well as elicit suggestions for the design and content of the future
intervention. This research directly addresses NIDA research priorities, including 1) relationships between
ENDS use and comorbidities (i.e. mental health concerns), and 2) ENDS use with concurrent use of other
tobacco products and other substances of abuse. This study will also serve as the foundation for a novel
cessation intervention for YA vape pod users with depression and/or anxiety.

Public health relevance
PROJECT NARRATIVE Research suggests that young adults (YAs) with depression and/or anxiety are at an increased risk of Electronic Nicotine Delivery Systems (ENDS), however, little is known about the socioecological risk factors for use among this vulnerable population. This project seeks to fill the gap in the literature by examining real-time and subjective risk factors for use of vape pods, a type of high dose nicotine ENDS device, among YAs with symptoms of depression and/or anxiety. The proposed project aims to identify real-time antecedents of vape pod use, and patterns of use (including concomitant use of other tobacco, alcohol, and marijuana) using Ecological Momentary Assessment, and then explore perceptions of vape pod use, as well as recommendations for future interventions, utilizing qualitative interviews of YAs with symptoms of depression and/or anxiety.